Immature neutrophil migration promotes inflammation during obesity

PROJECT SUMMARY
Obesity is associated with chronic, systemic, and low-grade inflammation that contributes to the development
of comorbidities such as metabolic disease. Anti-inflammatory agents have been shown to improve metabolic
markers in obese mice and humans, thus understanding the mechanistic drivers of inflammation during obesity
is critical to developing new treatments. During obesity, myeloid cells, including monocytes, macrophages, and
neutrophils, accumulate in the circulation and metabolic tissues and drive metabolic dysfunction by inhibiting
insulin signaling and promoting tissue fibrosis. Bone marrow (BM) hematopoietic stem and progenitor cells
(HSPCs) are dysregulated by obesity to favor the generation of myeloid cells at the expense of reduced
lymphoid cell output, driving systemic inflammation. Data from mice indicate that these alterations to the BM
are long-lasting and persist even after weight loss, which likely contributes to the worsened inflammatory
outcomes that are observed in mice and humans that regain weight.
To determine how the hematopoietic system is altered by obesity, I performed single-cell RNA sequencing on
HSPCs from lean and diet-induced obesity (DIO) mice. Stem cells from DIO mice are enriched for genes
related to cell cycle and DNA repair, suggesting dysregulation of their quiescent cycle. Immature neutrophils,
marked by histidine decarboxylase (Hdc), are key regulators of stem cell quiescence by secreting histamine,
but are recruited out of the bone marrow in DIO. These data suggest that immature neutrophil migration
promotes HSPC dysfunction in DIO, representing a possible therapeutic target for treating obesity-associated
inflammation.
In this proposed project, I will (Aim 1) determine how inhibiting the movement of immature neutrophils during
obesity affects HSPCs, metabolism, and systemic inflammation. I will then (Aim 2) determine how immature
neutrophils migrate during weight loss, how this affects myelopoiesis, and if inhibiting their migration during
weight loss improves metabolic and inflammatory outcomes. Our lab brings strong expertise in stem cell
biology, disease modeling, and therapeutic testing, and with support of experts in hematopoiesis and obesity, I
believe that the proposed project will further our understanding of the complex interactions between the
hematopoietic system, inflammatory cells, and metabolic organs during obesity.

Public health relevance
PROJECT NARRATIVE Obesity is characterized by chronic, low-grade inflammation that is driven by the accumulation of myeloid cells in the circulation and metabolic tissues which contributes to the development of comorbidities such as metabolic disease and diabetes. At the root of this inflammation, the hematopoietic system is altered by obesity to favor the output of myeloid cells at the expense of lymphoid and erythroid output, but the mechanisms driving these alterations are not fully understood. This proposal seeks to understand how the migration of immature neutrophils influences hematopoietic stem cells to promote myelopoiesis and inflammation during obesity.